Core B: Liver Metastasis Resource Core (LMRC)

ABSTRACT
Core B [The Liver Metastasis Resource Core (LMRC)] will supply human tissues and animal models to support
the four Projects in studying interactions between the liver microenvironment and the metastatic tumor cells that
colonize it. The Core will standardize operations across Projects through three functions: (1) Providing human
tumor tissue and blood specimens, along with thorough pathological annotation; (2) Producing novel transgenic
and orthotopic mouse models of liver metastasis and patient-derived xenografts (PDX) in mice using
human metastatic tumor specimens; and (3) Analyzing mouse and human biomarkers, as well as isolating
and characterizing circulating tumor cells (CTCs) and extracellular vesicles (EVs) using several approaches,
including a suite of NanoVelcro Assays, an emerging nanotechnology platform. Core B will provide these
resources under the aegis of well-coordinated and efficient central processes that maximize productivity and
cost efficiency for the Program.
The Core has the following specific aims:
AIM 1. Procure and process human biospecimens, for appropriate distribution to investigators.
AIM 2. Generate transgenic, orthotopic, and PDX mouse models of liver metastasis.
AIM 3. Collect and characterize blood components, including CTCs and EVs.
In summary, Core B will provide investigators with well-annotated tissue specimens, managed under
harmonized operating procedures across all collection sites and Projects. The Core will house all resources and
expertise, professional and technical, to generate physiologically relevant mouse models to support the Projects.
Centralized pathologic, clinical and technical services will enhance communication of data and analytical insight
across all Projects, supporting the Program's overall goals.

Public health relevance
PROJECT NARRATIVE Tumor metastasis to the liver is a leading cause of cancer death in the United States. This Program represents the only coordinated, multi-investigator effort nationwide to focus on the causes of and approaches to address liver metastasis. Core B will supply human tissues and animal models to support the four Program Projects in studying interactions between the liver microenvironment and the metastatic tumor cells that colonize it.